Research Methods, Measures, and Data Management Core

RESEARCH METHODS, MEASURES AND DATA MANAGEMENT CORE – ABSTRACT
The Advancing Cancer Control Equity Research Through Transformative Solutions in Patient Navigation Center
(ACCERT PN) Research Methods, Measures, and Data Management (RMMDM) Core co-led by Rinad Beidas,
PhD, Rachel Shelton, ScD, MPH, and Betina Yanez, PhD, will serve as a shared resource and incubator that
works synergistically in the development, implementation, and evaluation of ACCERT PN research projects. The
work of this Core will leverage the strengths and resources within the Northwestern Feinberg School of Medicine
and the Robert H. Lurie Comprehensive Cancer Center to advance the methods and measures for assessing
social determinants of health (SDOH), community engagement processes and outcomes, and cancer control
effectiveness and implementation outcomes. The ACCERT RMMDM Core will work to accomplish our broader
Center theme of implementing innovative multilevel patient navigation approaches within learning health systems
to address discrimination, medical mistrust, and other SDOH with the goal of mitigating barriers to clinical cancer
preventive services that represent stark health inequities and are high priority to Chicago's Black, Latinx, and
low-income Chinese communities. The RMMDM Core will support research activities for our signature SDOH
project on PN and our two community responsive projects on training of PN on community-driven cancer
survivorship topics such as sexual health after cancer and enhancing digital health literacy to develop
dissemination and communication tools to enhance community engagement in PN. The RMMDM Core will be
tasked with measuring community engagement, measure development and selection, ethical considerations,
and data analysis, sharing and management. The RMMDM Core is designed to ensure integration and synergy
across projects and will support dissemination efforts to a range of community, academic, healthcare system,
and policy partners. Fundamental to this Core are foundational values around the importance of early and
ongoing meaningful co-creation with community partners in pursuit of developing, implementing, conducting, and
evaluating multi-level research-community projects, from initiation to completion with the goal of enhancing future
sustainability and scalability. Our specific aims will focus on the following goals: 1) Data management and
compliance to ensure harmonization across data, methods, measures, and analysis efforts across the ACCERT
PN research projects and ensure that all projects follow NIH and NCI Data Sharing policies; 2) engage and
collaborate with community partners around measure development and selection, dissemination, unintended
consequences of data collection and sharing, and evaluation of community engagement and; 3) leverage our
exceptional environment at Northwestern in outcome and measurement science to compile, identify, apply, and
develop measures to assess the impact of multilevel interventions on cancer control outcomes, SDOH outcomes,
and equitable implementation outcomes.